Neural Disconnection and Errant Visual Perception in Psychotic Psychopathology

The NOSI and RFA for this application do not require a project abstract or narrative. However, these two documents are marked as required in the online application and generate error messages if no documents have been uploaded, thereby preventing the submission of the application. This document has been uploaded to remove the error messages.

Public health relevance
The NOSI and RFA for this application do not require a project abstract or narrative. However, these two documents are marked as required in the online application and generate error messages if no documents have been uploaded, thereby preventing the submission of the application. This document has been uploaded to remove the error messages.